Learning Health System Embedded Scientist Training and Research Center

ABSTRACT – UCSF E-STaR OVERALL
The aspirations of an integrated Learning Health System (LHS) are to deliver care that is of the highest quality,
is safe, and is optimally efficient. These goals guide all UCSF-affiliated health systems, including UCSF Health,
SF Health Network/Zuckerberg SF General and the SF Veterans Affairs Medical Center. The diversity of
patient populations and delivery systems represented by UCSF-affiliated health systems, along with their
evolution as integrated LHS, is a ripe, natural training environment for developing LHS scientists. To achieve
greater impact, UCSF needs a larger workforce of LHS scientists from diverse backgrounds, working in teams
with clinical operators, data stewards and informaticians, and engaged with multiple stakeholders (patients,
caregivers, clinicians, institutional leadership) to co-produce real-time improvements in practice patterns,
patient-centered outcomes, and health system performance. As an AHRQ/PCORI-sponsored LHS K12 Career
Development Program and LHS Center of Excellence, UCSF has designed an outstanding research training
and career development program for 8 individuals who have already demonstrated an impact. This UCSF E-
STaR Center proposal will create and scale up LHS-specific training and research infrastructure: Aim 1. To
establish multidisciplinary Cores that share resources and facilities with healthcare systems to
support research and training for LHS scientists, particularly in areas of embedded research training,
patient and stakeholder engagement, informatics, and outcome evaluation. The Administrative Core (AC)
will provide overarching Center leadership, stakeholder engagement and coordination, recruitment, program
evaluation, and internal and external communications. The Research Education Core (REC) will implement the
Scholar training program; the Research and Data Analysis Core (RDAC) will provide consultation and services
for study design and analysis, facilitating data access and dedicated IT support; Aim 2. To enroll Scholars
from diverse backgrounds, and provide them with the research, engagement, and leadership skills
necessary to pursue successful careers as LHS scientists. The AC and REC will coordinate recruitment,
training, and retention activities. Performance and outcomes will be captured in the Program Evaluation; Aim
3. To enable embedded research that advances and continuously improves healthcare quality, equity,
and patient-centered outcomes, and to disseminate results locally and nationally. RDAC will implement
processes to systematically ensure patient-centered outcomes are measured, captured, and aggregated
across embedded research projects. Expected Outcomes: At end of 5 years, the UCSF LHS E-STaR Center
will have trained >60 Scholars across at least 6 unique health systems, and provided consultative LHS support
to >100 additional scientists. Their research projects will increase the quality and health outcomes for patients
of all backgrounds, with results disseminated through local health systems, publications in the medical
literature, and presentations at national meetings.

Public health relevance
PROJECT NARRATIVE – UCSF E-STaR OVERALL A Learning Health System delivers high quality, safe, and optimally efficient care, at the right time to the right people, optimizing the care delivery system’s performance by generating and acting on meaningful data from the process of care. The UCSF E-STaR Center will speed the integration of interventions/evaluations into practice change, using methodologies that advance and continuously improve health care quality, equity, and patient-centered outcomes, disseminating findings and processes to local and national audiences.